Examining mobility restrictions through the lens of post-stroke apathy

PROJECT SUMMARY
Stroke is a leading cause of long-term disability worldwide, leaving many with restricted mobility that contributes
to progressive functional decline, reduces quality of life, and increases the risk of recurrent stroke. Rehabilitation
interventions are designed to enhance mobility post-stroke by reducing motor impairments and walking capacity
limitations. However, post-stroke mobility is a multifactorial construct that is only partially explained by motor
impairments, and motor-centered treatment approaches have a limited impact on walking performance in daily
life. This suggests a more comprehensive understanding of the non-motor sequelae of stroke that influence
mobility is necessary. Here, we posit that post-stroke apathy is an important factor to examine. Apathy, affecting
over one-third of stroke survivors, is rarely studied in neurorehabilitation. Defined as a psychiatric syndrome
characterized by a loss of motivation and reduced self-driven, goal-directed activity, apathy impacts effort-based
decision-making, reducing willingness to exert effort for rewards due to altered sensitivity to rewards or effort.
This provides a theoretical basis for a potential negative association between apathy and mobility, which remains
untested. Additionally, the neural mechanism underlying post-stroke apathy is not well understood. Emerging
research suggests that lower functional connectivity of brain areas involved in reward and salience processing
are neural signatures of apathy in older adults. Yet, functional connectivity correlates of post-stroke apathy are
poorly understood. The overall objective of this Katz Early-Stage Investigator Research Project Grant proposal
is to determine the association between post-stroke apathy mobility and identify the functional connectivity
signatures of post-stroke apathy. To accomplish this, we will conduct a cross-sectional observational study with
three aims in a single cohort of 125 participants with chronic stroke. We will study two aspects of mobility post-
stroke– habitual gait speed and community mobility. Aim 1 is designed to determine the relationship between
post-stroke apathy and gait speed reserve, where gait speed reserve is the difference between one’s habitual
gait speed and the speed that would minimize the total effort to move a given distance. Aim 2 will determine
how post-stroke apathy is related to community mobility. Community mobility will be operationalized as a
comprehensive combined metric of three commonly used measures – steps per day, GPS-derived activity space,
and life-space mobility. Finally, Aim 3 will examine the association between post-stroke apathy and functional
connectivity signatures of apathy using resting state-functional MRI. People with stroke who have a range of
apathy severity will complete the procedures necessary for these aims over two sessions that take place one
week apart. Successful completion of these aims will 1) lead to a more comprehensive understanding of post-
stroke mobility determinants, catalyzing a paradigm shift in neurorehabilitation to consider neuropsychiatric
symptoms as necessary treatment targets to improve mobility, and 2) delineate a potential neural mechanism of
post-stroke apathy, essential for developing effective interventions to prevent or mitigate apathy after stroke.

Public health relevance
PROJECT NARRATIVE Apathy is a psychiatric syndrome that occurs in more than one-third of stroke survivors. It is defined as a loss of motivation that can manifest as a reduction in self-driven, goal-directed activity. This project seeks to understand the association between apathy and restricted mobility post-stroke and identify the neural correlates of post- stroke apathy. Ultimately, this line of work will lead to the development of new therapeutic interventions that consider the interaction between apathy and physical rehabilitation to promote meaningful community mobility and reintegration to life after stroke.